FCF - SR Component

FLOW CYTOMETRY CORE (FCC) – PROJECT SUMMARY
The Flow Cytometry Core (FCC), in existence since 1982, is a state-of-the-art Shared Resource that
provides University of Virginia Cancer Center (UVACC) investigators access to high-quality, cost-effective flow
cytometry services, expertise and technology. The services and expertise offered by the FCC play a key role in
the study of many types of cancer, as well as the immune response to cancer. The FCC incorporates a variety
of technologies into its services based on the needs of the UVACC Members, thus enhancing the scope and
quality of cancer research performed at UVA. The available instrumentation is compatible with a wide array of
flow cytometric applications, such as subpopulation identification/quantification, molecular detection,
measurement of DNA and RNA content, apoptosis, transcriptional activity, cell viability, membrane potential,
extracellular vesicles, cell sorting, and bead-based immunoassays. The FCC staff members are experienced,
highly qualified, and SCYM-certified by ASCP. Direct collaborations with UVACC investigators produced novel,
published methods and approaches for studying cancer. In addition to providing extensive training in flow
cytometry theory and instrumentation, FCC staff provide consultation in experimental design, sample
preparation, and data analysis. The facility recently added a site license with Astrolabe Diagnostics, a full-
service bioinformatics platform that combines state-of-the-art learning with literature-based analytics to assist
UVACC investigators with the complexity of high-dimensional data generated in the flow core. Specialized
training classes, web-based training, and consultation are offered for researchers interested in acquiring a
better understanding of the principles and techniques employed by this technology and prefer to directly
acquire and/or analyze their own samples. Researchers have the option of utilizing the expertise of the FCC
staff or performing their own analyses.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.